2023 Physical Virology GRC and GRS

Project Summary
Viral infections involve processes from atomic-scale regulation of ionic transport, to macromolecular self-
assembly and membrane budding, to global epidemiology. Physical Virology studies these processes as a
paradigm for the intersection of fundamental physical laws and emergent biological function. This biennial GRC
is the only international meeting for researchers from the diverse disciplines relevant to Physical Virology, and
is unique for its simultaneous focus on fundamental and applied aspects of virology. The scientific objectives of
this GRC are to (1) uncover the biophysical principles that govern viral lifecycles, (2) use this knowledge to
advance development of vaccines, antiviral drugs, and engineering virus-based biomaterials, and (3) broaden
physical virology to leverage recent advances in cell biology and protein design. The COVID-19 pandemic
highlights the need for these cross-disciplinary approaches to understand viral biology, predict their global spread
and impact, and develop new treatments. The 2023 Physical Virology GRC will be held January 22-27 in Il
Ciocco, Italy with the accompanying Gordon Research Seminar (GRS) on January 21-22. Our conference goals
are in-line with the missions of NIAID to support basic and applied research on causative agents of infectious
diseases, and NIBIB to improve health by accelerating development of biomedical technologies.
The Physical Virology GRC/GRS have three independent but synergistic Aims. Aim 1 will promote and
broaden interdisciplinary research in Physical Virology. We have 29 invited speakers (27 confirmed) and nine
discussion leaders (all confirmed) at the frontiers of physical virology. To foster cross-disciplinary collaboration,
sessions include speakers from different disciplines focusing on common aspects of virology. The conference
will expand physical virology by including recent advances in (1) understanding virus-host interactions (e.g. virus-
host protein interaction networks and co-evolution of viruses and host immune systems), (2) assembly of virus-
like cages in other systems, and (3) emerging knowledge on COVID-19. The program promotes collaboration
and networking through informal discussion times and 4 poster sessions. Aim 2 will increase the diversity, equity,
and inclusivity (DEI) of the Physical Virology community. Of our invited speakers and discussion leaders, 53%
are women, 10% are URMs, and 34% are early-career researchers. We will amplify diversity when selecting
short talks. At a Power Hour, participants will discuss how to address issues faced by underrepresented groups
in science. Aim 3 will provide training and career development for early career researchers. Poster presentations
will be accepted from all students and postdocs, and they will be given priority for selection of short talks from
abstracts. The GRS is organized by a graduate student and postdoc for this target group. The (to be confirmed)
GRS keynote speaker is Dr. Barney Graham, former Deputy Director of the Vaccine Research Center at NIAID.

Public health relevance
Project Narrative The GRC Physical Virology conference brings together researchers with scientific expertise in virology, physics, engineering, mathematics, chemistry, materials science, and computational science who (1) share an objective to uncover the biophysical mechanisms that drive and regulate viral infections and, (2) strive to apply the principles that control virus self-assembly and structural dynamics to the development of nanotechnology platforms, for gene/drug delivery, vaccines, and therapeutics. These objectives are commensurate with the missions of NIAID to support basic and applied research on causative agents of infectious diseases, and NIBIB to improve health by accelerating development of biomedical technologies.